Characterization of a ubiquitin-independent pathway for proteasomal degradation

PROJECT SUMMARY/ABSTRACT
The proteasome is the main intracellular protease and is responsible for degrading thousands of different
proteins. The main signal for degradation by the proteasome is thought to be the post-translational attachment
of ubiquitin molecules onto a substrate protein. While some proteasome substrates have been reported to be
targeted to the proteasome without the use of ubiquitin, the extent and mechanism of ubiquitin-independent
proteasomal degradation remain unclear. We have recently identified hundreds of peptides that, when fused to
the C-terminus of enhanced green fluorescent protein (EGFP), are degraded by the proteasome in a ubiquitin-
independent manner. Here, we propose to investigate the mechanism of this ubiquitin-independent
degradation and determine the endogenous substrates of this pathway.
First, we will determine if the EGFP fusion substrates are recognized by the proteasome directly, or if they are
shuttled to the proteasome by an intervening factor (Aim 1). Next, we will characterize the interaction between
the receptor and substrates using a combination of genetic and biochemical methods (Aim 2). Finally, we will
identify endogenous substrates of the ubiquitin-independent pathway (Aim 3). Overall, these experiments will
characterize in detail this newly-uncovered ubiquitin-independent proteasome pathway, which may have
profound implications for our understanding of the proteasome and of protein homeostasis more generally.
I will perform this research as a postdoctoral fellow under the mentorship of Dr. Stephen Elledge at Brigham
and Women’s Hospital/Harvard Medical School (HMS) and into my future independent research career at a top
U.S. institution. To accomplish my proposed aims, I will need to learn essential skills in the K99 period from Dr.
Elledge pertaining to advanced genetic screening techniques. I have assembled a team of collaborators and
advisors from around HMS (Dr. Alfred Goldberg, Dr. Wade Harper, Dr. Eric Fisher, Dr. Phil Cole, and Dr.
Eugene Oh) who complement my skill set and will help me effectively accomplish my proposed projects and
prepare for my future independent career. The local training environment in the Elledge lab and at HMS will
support me with all the materials, equipment, and professional development opportunities necessary to
become a world-class researcher. Receiving the K99/R00 Pathway to Independence Award would provide me
with critical resources to realize my project and career goals.

Public health relevance
PROJECT NARRATIVE Many diseases, including Azheimer’s, Parkinson’s, and Huntington’s diseases, are caused by an abnormal accumulation of proteins, yet the pathways that degrade proteins are not fully understood. The goal of this proposal is to characterize a ubiquitin-independent protein degradation pathway that may be involved in degrading misfolded and/or oxidatively-damaged proteins. This work will provide fundamental insights into protein degradation and may lead to new methods for treating diseases caused by aberrant proteins.